ADMINISTRATIVE CORE

The Administrative Core provides a cohesive administrative structure for scientists, the business administrator and consultants on the Program Project. Specifically, the Administrative Core: devotes 5% effort on behalf of the Core Leader to coordinate administrative activity of all Program Project personnel with the Business Administrator; arranges and schedules weekly meetings of Program Project investigators; monitors all grant expenditures; ensures compliance with NIH guidelines; provides monthly financial statements to investigators; orders all material necessary for scientific research; and provides support for 3 expert consultants each year, who visit Denver to critique all aspects of the Program Project.

Public health relevance
The Administrative Core provides support to the Core Leader (see Budget Justification for itemized percent effort) for administrative and desk support and for consultants to the Program Project.